Developing a selective TRPC3 ion channel inhibitor for epilepsy treatment

Project Summary
Epilepsy is one of the most common brain disorders. Current drugs have limited efficacy. Identifying new
targeted drugs that can be used as safer, more effective therapies is in urgent unmet need. Selective inhibition
of the transient receptor potential canonical 3 (TRPC3) emerges as a novel strategy to impede epilepsy.
However, the currently best selective TRPC3 inhibitor, Pyr3, has poor metabolic stability and has significant
safety liabilities. We recently published the discovery of a patented Pyr3 analog, JW-65, which has significantly
improved metabolic stability and safety profiles. It has good brain penetration and retention, directly binds to
TRPC3, and shows better efficacy than an existing drug phenytoin in a head-to-head comparison in an epilepsy
mouse model. SEAK is licensing this patented scaffold and proposes in this Phase I STTR to thoroughly de-risk
JW-65 as a potentially viable clinical candidate for targeted epilepsy therapy.
Aim 1. Determine toxicological profiles, potential off-targets against a panel of physiologically
important targets, major CYP inhibitions and inductions, membrane permeability, transporter effects,
plasma binding and stability, and pharmacokinetic (PK) profiles to further de-risk JW-65. We have already
confirmed the direct binding to and functional inhibition of TRPC3 by JW-65 and demonstrated its excellent drug-
like properties. We have also showed that JW-65 has good PK properties with i.p. injection. In this aim, we will
first perform large scale synthesis of JW-65 to support subsequent biological evaluations. We will then
comprehensively evaluate its safety, off-targets, ADME properties, and industry standard rat PK (i.v. and oral)
profiles to comprehensively de-risk JW-65 as a clinical candidate. Milestones: (1) three grams of JW-65
synthesized and rigorously characterized; (2) demonstrate the safety profiles and drug like properties of JW-65
as a viable candidate; (3) determine PK profiles and oral bioavailability of JW-65.
Aim 2. Evaluate in vivo efficacy of JW-65 for its ability to suppress acute seizures in multiple models
in both mice and rats. We will first assess the efficacy of JW-65 on acute seizures in rats induced by pilocarpine,
using both Pyr3 and benzodiazepines (the first-line drugs for prolonged seizures) as references. To further
increase the rigor and avoid any model- or species-specific findings, the anti-seizure effects of JW-65 will be
validated in the mouse kainic acid model and flurothyl model. Milestones: (4) demonstrate efficacy against acute
pilocarpine seizures in rats (~50% reduction in behavioral seizure scores or EEG spikes); (5) demonstrate
efficacy against flurothyl-induced seizures in mice (~50% increase in latencies to the first myoclonic jerk and
generalized tonic-clonic seizure); (6) demonstrate efficacy against 6 Hz-induced seizures in mice (~50%
decrease in behavioral seizure scores); (7) demonstrate efficacy against spontaneous seizures (~50% decrease
in total number of SRSs per day).
Future directions: In Phase 2, SEAK will perform comprehensive IND-enabling studies for JW-65.

Public health relevance
Project Narrative There is a significant unmet medical need to develop more effective drugs for epilepsy therapy. In this Phase I STTR project, SEAK Therapeutics LLC proposes to comprehensively de-risk a patented, selective TRPC3 inhibitor, named JW-65, as a potential targeted drug for epilepsy. Success of this Phase I study will provide SEAK Therapeutics the foundation for entrance of a Phase II to perform IND-enabling studies with JW-65 or its derivatives as a new therapeutic agent for epilepsy treatment.